Epi25 Clinical Phenotyping R03

PROJECT SUMMARY Clinical genetic data suggests that specific categories of epilepsy have genetic contributors, and there may be some overlap between categories. The Epi25 Collaborative was formed among more than 40 cohorts from around the world to sequence as many as 25,000 genomes or exomes. As of 2017, the collaborative has sequenced more than 13,000 exomes and clinical data has been collected for more than 8,000 cases. This project will complete the collection and review of the clinical data for each sample in the Epi25 collection to facilitate the translation of genomic and clinical discoveries into improved care for patients. The clinical and genomic data from Epi25 will be a global resource, shared with the research community for years to come. Epi25's governance structure, membership, and other information are available online at www.epi-25.org. In this project, clinical data is entered by contributors into Red Cap forms or uploaded directly into the Epi25 database. The clinical data is then checked by a computer algorithm that looks for key eligibility criteria for each participant. Errors and missing data are sent to the Phenotyping Coordinator to review and resolve, with the help of the contributing site.

Public health relevance
PROJECT NARRATIVE In 2014, collaborators from around the world created the Epi25 Collaborative to exome sequence as many as 25,000 patients with epilepsy. The collaborative has more than 6,200 exomes generated in year 2016, an additional 7,500 on sequencers in 2017, and more than 1,000 ready for sequencing in 2018. This project will review and correct errors for the descriptive epilepsy data for each sample sequenced in Epi25, to reveal the genetic underpinnings of common epilepsies.